NCI RESEARCH LEVEL NUTRIENT AND FOOD GROUP DATABASE

INITIAL AWARD TO PROVIDE THE NCI WITH THE RESEARCH LEVEL NUTRIENT AND FOOD GROUP DATABASE TO PROVIDE ITS EXTENSIVE LIST OF NUTRIENTS AND FOOD COMPONENTS ON ITS PUBLIC USE FOOD FREQUENCY QUESTIONNAIRE.